Effect of iodized salt in pregnancy and lactation on infant neurodevelopment in rural Ethiopia

PROJECT SUMMARY
Mild-to-moderate iodine deficiency (ID) remains widespread worldwide among pregnant and lactating women
who have higher dietary requirements than the general population. Iodine is required for the synthesis of
thyroid hormone, which is essential for human brain development, particularly visual attention, fine motor
development, language and memory. The benefits of iodine supplementation for severe ID during pregnancy
and in childhood have been established. However, the effects of iodine supplementation in settings with mild-
to-moderate ID and during lactation remain unclear. Furthermore, few trials to date have examined the effects
of iodine supplementation in pregnancy or lactation on iodine-specific neural functions. In response to NICHD
NOSI (NOT-HD-19-039), we present a unique opportunity to build upon an ongoing, randomized controlled trial
(RCT) to address the consequences of iodine deficiency on fetal and infant neurodevelopment in a population
of mild-to-moderate iodine deficiency in rural Ethiopia. In the funded parent pregnancy trial, women in early
pregnancy are randomized to receive a package of strengthened nutrition support (including monthly supply of
iodized salt) and/or a package of infection control. The funded parent pregnancy trial will determine the effect
of the interventions on infant birth outcomes. With support from this award, we propose to add a lactation
intervention utilizing an efficient 2x2 factorial design and randomize women after delivery to receive a) an
intensive iodized salt intervention, including provision of a monthly supply of high-quality, adequately iodized
salt and counseling regarding appropriate storage and use, or b) standard care, until 6 months post-
partum. Our overall goal is to examine the effects of iodine in pregnancy and lactation on infant brain function,
as well as maternal and infant iodine status and thyroid function. The specific aims of this project are to: (1)
determine the effects of an intensive salt intervention in pregnancy and lactation on infant visual evoked
potentials (primary outcome), as well as visual attention, motor function, and head circumference at 6 months
of age; (2) determine the effect of the iodized salt intervention on maternal breast milk iodine concentration, as
well as infant iodine status and thyroid function; and (3) examine interactions between iron and iodine on
thyroid function in pregnancy and lactation. Globally, salt iodization is the primary intervention strategy for
iodine delivery. To our knowledge, this trial will be the first rigorous, adequately powered RCT of high-fidelity
iodized salt provision along the continuum of pregnancy and lactation in a setting of mild-moderate iodine
deficiency. These discoveries will improve our understanding of the role of iodine in early human brain
development in order to develop effective targeted intervention strategies to improve iodine status and
neurodevelopmental outcomes in children worldwide.

Public health relevance
PROJECT NARRATIVE Iodine deficiency is one of the most common and preventable causes of neurodevelopmental impairment worldwide. In a randomized controlled trial of high-fidelity, iodized salt provision along the continuum of pregnancy and lactation, we will determine the effects of iodine on early human brain development utilizing novel, multi-modal measures of neural function. This study will generate foundational knowledge about the role of iodine in the first 1000 days of life and inform the design and delivery of interventions to optimize the potential of children worldwide.